INTERACTIVE VIDEODISC SMOKING CESSATION INTERVENTION

This project will produce an interactive videodisc-based (IVD) smoking cessation system for use in medical office settings. The IVD system will assist providers in helping patients stop smoking, by using an interactive smoking cessation program. This project will produce a stand- alone kiosk with printer that is suitable for use in medical offices. The IVD system offers several potential advantages over other approaches to smoking cessation, including lower personnel costs, increased efficiency and efficacy. The effectiveness of the IVD-based intervention will be evaluated with 500 primary-care patients in a randomized clinical trial with a "physician-advice-only" control condition.